Generation of New Mouse Models of Low Nephron Numbers to Understand Pathogenesis of AKI and CKD in Humans Born Preterm

Abstract
The population of humans born preterm (~24-37 w gestation) is growing rapidly as a result of advanced
medical care. Unfortunately, humans born before 36 w gestation have incomplete kidney development and
low nephron numbers, which has been hypothesized to cause increased risk of chronic kidney disease (CKD)
and hypertension later in life. Premature infants also have a high incidence of acute kidney injury (AKI). Due
to limited animal models and few kidney biopsy samples, the pathogenesis of AKI and CKD as well as the
cellular response to kidney injury and repair in this population is poorly understood. We have developed new
mouse models of congenital low nephron numbers (50-70% of controls) by inhibiting Ret tyrosine kinase
during kidney development. Preliminary studies showed that kidneys with low nephron numbers had an
accelerated AKI to CKD transition following ischemia-reperfusion injury (IRI). Since low nephron numbers is
known to cause glomerular hyperfiltration and higher metabolic demands for absorption of high filter load of
Na+ at the single nephron level, we examined kidneys for stress response with autophagy. We found that
kidneys with low nephron numbers were more hypoxic and had higher autophagic response 4 w post-IRI.
Therefore, we have planned studies to test the following hypotheses: 1) Low renal reserve in underdeveloped
kidneys contributes to high risk of CKD, and 2) High metabolic stress may exceed autophagic compensation
and lead to CKD development. Aim 1 will generate and validate new mouse models with a range of low
nephron numbers (25-70% of control) that resemble human underdeveloped kidneys. We will take novel
chemical and genetic approaches using mice harboring a floxed and mutant Ret allele that renders it
susceptibility to a small molecule inhibitor. We plan to inhibit the engineered Ret activity with the chemical
inhibitor or delete Ret gene specifically in the ureteric bud during mid-late gestation. Kidney development and
renal structure and function will be characterized. Aim 2 We will use these new mouse models to address the
questions of whether kidneys with low nephron numbers: 1) are more susceptible to AKI with more severe
injury and incomplete recovery, and 2) have increased risk of CKD in the absence of prior history of AKI or
more rapid CKD development after AKI exposure. We will also study clinically relevant models of neonatal
AKI using newborn mice with low nephron number to test the impact of AKI on the developing kidneys. Aim
3 will characterize autophagy as a stress response to hypoxia and metabolic perturbations in underdeveloped
kidneys by examining the role of autophagy in cell quality control as well as during the AKI to CKD transition.
Studies are designed to test whether a decline in autophagic capacity and flux in response to physiologic and
pathologic stress contributes to CKD development, and whether reducing metabolic stress delays CKD
development. The overall goal is to obtain much needed knowledge that could be used in the future to prevent
and treat kidney disease in the growing population of humans born preterm.

Public health relevance
Narrative Each year, 15 millions of premature babies are born and a vast majority of them survive. Because humans born preterm have low kidney reserve due to underdeveloped kidneys, it has been hypothesized for decades that low renal reserve contributes to high risk of chronic kidney disease and hypertension later in life. We have now generated mouse models of low numbers of functional unit in the kidney called nephron to understand biology of chronic kidney disease in the growing population of humans born preterm.